Implementing an evidence-based mHealth diet and activity intervention: Make Better Choices 2 for rural Appalachians

ABSTRACT
We propose a type 1 hybrid effectiveness-implementation study to test an adapted evidence-based
intervention and explore critical implementation issues, including feasibility, acceptability, and costs, that
influence scale-up and sustainment. We focus this adaptation, effectiveness, and implementation study on
underserved rural residents, a population that maintains extremely high rates of suboptimal diet and sedentary
behaviors, placing them at elevated risk for cardiovascular disease, obesity, diabetes, cancer, and other
chronic conditions. Within the vulnerable low socioeconomic status population of rural residents, Appalachian
Kentuckians experience even worse health outcomes, including among the highest rates of morbidity and
mortality in the nation. Such adversity is exacerbated by and associated with inadequate community resources.
Increasingly, however, Appalachian residents and other vulnerable populations are gaining access to
modalities that may be useful in addressing these health challenges, including internet connectivity and nearly
ubiquitous cell phone use. Despite this accelerating technology use, the evidence base on personal
technology-associated interventions (mHealth) in a rural, high need population remains sparse. We propose
finalizing adaptation and testing an evidence-based multicomponent mHealth intervention, Make Better
Choices 2 (MBC2), a behavioral program consisting of personalized health coaching, an app, accelerometer,
and financial incentives. In a recent randomized controlled trial among urban adults, MBC2 produced large,
sustained diet and physical activity improvements by leveraging effective behavior change techniques,
including goal-setting, self-monitoring, accountability, and support. To prepare for the implementation of this
successful intervention with a new population marked by extreme health inequities and sparse resources, our
team has engaged in extensive foundational efforts based on the Dynamic Adaptation Process framework.
These include: (1) completing focus groups and key informant interviews to assess the feasibility and
acceptability for rural Appalachian residents to use the MBC2 program; (2) undertaking a comprehensive
community inventory to reveal existing and needed resources; (3) engaging stakeholders in community and
academic team meetings, including community forums and CAB meetings; and (4) identifying MBC2
programmatic and structural elements in need of adaptation. With this extensive preliminary activity, we now
propose a type 1 hybrid effectiveness-implementation trial in which we: (1) finalize adaptation by wireframe and
usability testing MBC2 with local Appalachian residents; (2) conduct a RCT to test the effectiveness of the
adapted MBC2 compared to an active control arm; and (3) explore implementation outcomes and contextual
factors, with a focus on sustainment. This project aspires to demonstrate that systematic adaptation and
implementation of an evidence-based intervention can lead to meaningful and sustained behavioral changes,
and to prepare for potential scale-up and sustainment of the intervention to maximize its public health impact.

Public health relevance
PROJECT NARRATIVE Rural residents, especially Appalachians, have among the nation’s highest rates of cardiovascular disease (CVD), diabetes, and obesity, all associated with unhealthy diet and lack of physical activity. New tools, including personal technology, offers an opportunity to make long lasting behavioral changes and improve health. We will test a culturally adapted evidence-based multicomponent mHealth intervention, Make Better Choices 2 (MBC2), a behavioral program consisting of personalized health coaching, an app, accelerometer, and financial incentives and, explore optimal implementation and sustainment approaches.